Investigating the Role of VISTA in Driving Immune Evasion in Acute Myeloid Leukemia

Abstract
Acute myeloid leukemia (AML) has a high mortality rate following standard therapies. Blockade of immune
checkpoint receptors (ICRs) has revolutionized therapy for solid tumors, yet it has not significantly improved
survival in AML patients. This unmet clinical need calls for the identification and targeting of alternative ICRs.
VISTA, a next-generation ICR, is a promising target for cancer therapy; however, its role in modulating
antileukemia immunity remains unclear and there are significant knowledge gaps in understanding the signaling
mechanisms of VISTA. Our preliminary studies suggest that VISTA intrinsically promotes the differentiation of
immunosuppressive myeloid cells (MDSCs). This proposal aims to test the hypothesis that blocking VISTA-
mediated signaling in myeloid cells will reduce MDSC differentiation and improve the immunogenicity of leukemic
cells, thereby leading to effective antileukemia immunity. To address this hypothesis, we will first investigate the
signaling mechanisms of VISTA in myeloid cells (Specific Aim 1). Next, we will evaluate the therapeutic potential
of VISTA-specific inhibitors in multiple preclinical models of AML (Specific Aim 2). The successful completion of
these studies will establish VISTA as a critical ICR in AML and warrant the targeting of VISTA for treating AML.

Public health relevance
Narrative Immunotherapies blocking immune checkpoint receptors have revolutionized therapy for solid cancers but have not significantly benefited patients with acute myeloid leukemia (AML). This project will interrogate the mechanisms by which a next-generation immune checkpoint protein VISTA drives immune evasion in AML. Proposed studies will establish VISTA as a relevant target for treating AML.